Studies of P-glycoprotein Drug Interactions - Administrative Supplement for Undergraduate Summer Research

PROJECT SUMMARY/ABSTRACT (of the original funded project)
P-glycoprotein (Pgp) is a molecular pump that detoxifies cells by transporting hundreds of structurally unrelated
toxins out of the cell. Pgp limits uptake in the intestines, and enhances excretion of drugs in the liver, kidney and
blood-brain barrier, of many drugs that are used for treatment of cancers, HIV/AIDS, psychiatric illnesses, and
cardiovascular conditions. It is among the seven most important transporters responsible for regulating drug
absorption and disposition that now require documentation of drug interactions for approval of any new drugs by
the US Food and Drug Administration (FDA). Pgp is an ATP-binding cassette transporter with two
transmembrane domains (TMDs) and two nucleotide-binding domains (NBDs). It uses ATP hydrolysis to pump
substrates across the cell membranes. Our recent X-ray structures of Pgp identified hydrophobic and aromatic
amino acids that contribute to binding of different inhibitors to the drug-binding site. In this proposal, we will test
the hypothesis that therapeutic drugs bind to different subsets of residues within defined subpockets in the TMDs
of the protein. Our general approach is to introduce tryptophans (Trps) at strategic positions in order to monitor
drug binding. The Trps will be introduced on the background of a new fully functional Trp-less Pgp, or a low-Trp
Pgp that retains three native conformationally sensitive Trps in the cytoplasmic domains. Using fluorescence
changes, such as quenching, and resonance energy transfer (FRET), we will map out sites of interaction of the
purified protein with prototypical substrates that occupy biochemically defined and distinct binding sites, as well
as those of common therapeutic drugs and newly identified inhibitors. We will further insert a fluorescent Trp
analog (L-Anap) into wild-type Pgp using the amber stop codon suppression strategy to explore monitoring drug
binding in biological cell membranes. By determining how drugs and inhibitors modulate the cooperativity and
conformational dynamics of this multidomain transporter, we will gain unique insight into the mechanisms of drug
binding and their effects on Pgp function. With these new approaches, we will address the molecular mechanism
and kinetics of drug/inhibitor binding, determine synergistic effects, and refine the mechanisms of drug-drug
interactions in Pgp. The information will pave the way to new analytical approaches to refine Pgp drug interaction
studies of old and new drugs, and will be invaluable to redesign drugs with clinically favorable pharmacokinetics
and accelerate pharmacotherapeutic developments.

Public health relevance
NARRATIVE P-glycoprotein is the cell's cleaning machine, pumping harmful substances to the outside of the cell. It is among the seven most important transporters responsible for regulating drug absorption and disposition that now require documentation of drug interactions for approval of any new drugs by the US Food and Drug Administration (FDA). By learning more about how P-glycoprotein recognizes the chemicals that it carries out of the cell, scientists may redesign drugs to prevent P-glycoprotein from interfering with their valuable effects in the treatment of many diseases.